Clinical, Imaging, and Pathological Studies in the Oldest Old: The 90+ Study

Project Summary
The 90+ Study was initiated January 1, 2003 as a population-based sample of oldest-old survivors of the Leisure
World Cohort Study (LWCS, enrollment 1981-1984). With more than 1,800 participants, The 90+ Study is one of the
largest and longest studies in the world of dementia, cognitive decline, disability, and frailty in the oldest-old. People over
90 are the fastest segment of the population and have the greatest public health impact as the risk of dementia is
extraordinarily high in these individuals, reaching a staggering 40% per year in centenarians. However, many oldest old
maintain superior cognitive performance well into their tenth decade and beyond (cognitive resilience), often in the
presence of neuropathological changes (cognitive resilience in the presence of pathology). Lifestyle, co-morbid
conditions, genetics, and other factors have been implicated in this cognitive resilience, but have not been well studied. In
this application, we extend our studies to investigate cognitive resilience in these remarkable individuals. In Aim 1, we
consider early (30 years earlier in the LWCS) and late (at age 90+) lifestyle and other factors in relation to cognitive
resilience. Factors related to the maintenance of superior cognitive abilities in the presence of pathology are investigated
in Aim 2. Taking advantage of our large cohort of 90+ year-olds in our imaging studies, we prospectively follow
individuals without dementia to estimate incidence of dementia and rates of cognitive decline in relation to MRI and PET
biomarkers in Aim 3. We analyze the role of low levels of multiple neuropathologic changes in the expression of
dementia in Aim 4. Finally, with this application, we will recruit the last living LWCS participants eligible for our study,
and complete ascertainment of all previously established outcomes in The 90+ Study (dementia, CIND, MCI, frailty,
disability, and mortality). We will make this dataset spanning almost four decades publically available to the research
community (Aim5).
With our extensive database, unique large cohort of well-characterized individuals, extensive and
multidisciplinary longitudinal follow-up, and innovative neuropathological and neuroimaging investigations, we are
ideally positioned to do studies of dementia and resilience in the oldest-old. Identifying factors related to cognitive
resilience and dementia, including modifiable lifestyle factors and imaging biomarkers, would contribute to our
understanding of aging in health and disease and provide potential targets for interventions to promote successful aging.

Public health relevance
Project Narrative People aged 90 and older (the oldest-old) are the fastest growing segment of the population and have the highest rates of dementia. Many oldest-old individuals, however, maintain superior cognitive performance (cognitive resilience) often despite the presence of Alzheimer disease (AD) and other neuropathologic changes. With clinical, imaging and pathological investigations, our goal is to identify lifestyle and other factors that contribute to resilience in this understudied and unique segment of the population.